Targeting NETosis for the Treatment of Tuberculosis

Abstract
Neutrophils are the most abundant and predominantly-infected cell type in the sputum, bronchoalveolar lavage
fluid, and caseum contents from resected lung tissue of active tuberculosis (TB) patients. Studies of TB in
mice, non-human primates, and humans have identified a correlation between neutrophil abundance and
increased disease severity. Although there is a growing appreciation for the association of increased neutrophil
abundance with active TB disease, it was still unknown if the presence of neutrophils in the lungs of active TB
patients is consequential, or if the neutrophils are bystanders reacting to an uncontrolled infection. In particular,
the details on how specific neutrophil responses and effector functions impact TB disease have remained
elusive. In response to Mycobacterium tuberculosis (Mtb) infection, neutrophils deploy a number of defenses
including the extrusion of neutrophil extracellular traps (NETs) via a process of cell death termed NETosis.
NETosis usually follows the general steps of 1) histone citrullination, 2) chromatin decondensation, and 3)
release of web-like chromatin structures decorated with antimicrobial granule proteins with the potential to
bind, trap, and kill pathogens. We have recently discovered that NETosis directly promotes Mtb
replication, where genetic or chemical inhibition of NETosis mediates better control of Mtb infection in vitro and
in vivo, thus validating NETosis as a potential target for host-directed therapies to treat TB. We have used
genetic and chemical approaches to mechanistically dissect the process of NETosis during Mtb infection,
which has identified a number of regulatory nodes that can be manipulated to lead to better control of Mtb
pathogenesis. We find that in response to Mtb infection in neutrophils, protein arginine deiminase 4 (PAD4)
citrullinates histones to decondense chromatin that gets packaged into vesicles for release as NETs in a
manner that promotes Mtb replication. We discovered that type I interferon (IFN), which has been associated
with NETosis in numerous contexts but without a known mechanism, promotes the formation of
chromatin-containing vesicles and NET release. In addition, we discovered a new autophagy-independent
role for the ATG5 protein in suppressing NETosis by blocking type I IFN-dependent induction of PAD4 activity
during Mtb infection, where increased NETosis in the absence of ATG5 expression in neutrophils leads to
susceptibility to Mtb. Multiple studies have linked increased levels of type I IFN signaling with TB pathology in
mice and humans. Based on our data that NETosis promotes Mtb replication and pathogenesis, NETosis
could contribute to the ways that type I IFN signaling impedes control of Mtb infection. In this proposal, we
will dissect how NETosis is regulated during Mtb infection (Aim 1), how NETosis contributes to Mtb replication
(Aim 2), and how NETosis contributes to loss of control of infection (Aim 3). By pursuing our Aims, we will
identify regulatory mechanisms to be targeted by HDTs aimed at blocking NETosis during Mtb infection as well
as determine what consequences result from blocking NETosis during Mtb infection.

Public health relevance
NARRATIVE Mycobacterium tuberculosis (Mtb) infection causes approximately 10 million new cases of tuberculosis (TB) and 1.5 million TB-related deaths each year. In order to develop new and more effective therapies, better understanding of Mtb pathogenesis is required. The proposed studies will provide critical insight into the pathogenesis of TB and the immune requirements for successful control of Mtb infection.